NCCAT: National Center for CryoEM Access and Training

Project Summary/Abstract
The National Center for CryoEM Access and Training (NCCAT), based at the New York
Structural Biology Center, provides access to state-of-the-art cryo-electron microscopy
(cryoEM) equipment. The equipment and services include high-end microscopes with
direct detectors, screening microscopes, specimen preparation robots and other ancillary
equipment required to solve structures to the highest possible resolution using cryoEM
methods. A highly qualified technical team provides direct support, guidance and
assistance, ensuring the highest quality structures are resolved quickly and efficiently. A
cross-training program offers training to users across the full spectrum of skill levels and
career goals.
This request is for supplemental funding to purchase Gatan BioContinuum energy filters
to extend the capability of our 300-keV Titan Krios cryo-transmission electron
microscopes (Krios#3 and Krios#4) for data collection supporting state-of-the-art high-
resolution data collection services. Thereby, this instrumentation will benefit all users of
center by increasing the capability and capacity of these instruments and provide
outstanding training opportunities to the next generation of biomedical scientists. NCCAT
has a proven track record of maintaining various high-end imaging systems, strong
institutional support, and a large user base, guaranteeing that the instrumentation will be
used to its maximum potential for years to come.

Public health relevance
Project Narrative CryoEM has unique capabilities for studying biological systems that are inaccessible through other structural methods; furthermore, recent technical advances in single- particle cryoEM enable it to generate reliable atomic models of complete and fully functional macromolecular complexes imaged in near-native conditions. NCCAT provides nationwide access to cryoEM instrumentation, technical support and cross-training to allow the production and analysis of high-resolution cryoEM structures. The requested imaging filters will be installed on two existing 300-keV Titan Krios cryo-transmission electron microscopes to maintain our instruments at the state-of-the-art and expand the data collection capabilities for single particle methods, thereby accelerating biomedical research discoveries across the country.